Staphylococcus aureus induced itch and neuro-immune signaling in skin infections

PROJECT SUMMARY
Itch is an unpleasant sensation that evokes a desire to scratch. While itch accompanies many skin infections, a
causative role for microbes in itch has not been previously investigated. Itch-induced scratching can contribute
to significant skin damage and bacterial pathogenesis. Here, we investigate the role of the human bacterial
pathogen Staphylococcus aureus and its secreted proteases in driving itch and inflammation. S. aureus
colonizes 90% of skin lesions caused by Atopic Dermatitis, a disease characterized by chronic itch. S. aureus
also causes impetigo, a contagious skin disease characterized by itchy lesions. We hypothesize that S. aureus
secretes proteases that can directly act on host sensory neurons to drive itch, scratch-induced skin damage, and
neuroimmune crosstalk. Our preliminary data shows that S. aureus epicutaneous infection of mice induces
robust itch behaviors (alloknesis, spontaneous itch) and resulting skin pathology. Using isogenic mutant strains,
we find that secreted S. aureus proteases, and in particular the serine protease V8 (SspA) is required for itch
production during infection. In Specific Aim 1, we will determine the role of S. aureus V8 protease in driving itch,
neuronal activation, and skin inflammation. We will utilize isogenic S. aureus mutant and complemented strains
for V8, as well as recombinant V8 to elucidate the necessity and sufficiency of this protease in inducing itch,
scratch induced damage, and inflammation caused by S. aureus. Itch is mediated by dorsal root ganglia (DRG)
sensory neurons. DRG neuron calcium imaging will be performed to investigate specific neuronal responses to
V8 protease. Cheek intradermal injections and neurobehavioral analysis will be performed to distinguish itch vs.
pain behaviors in mice. In Specific Aim 2, we will determine whether neurons and host cells detect S. aureus
V8 protease through specific protease-activated receptors (PARs). Preliminary data indicates that PAR1 may be
an important host receptor that is activated by V8. We will utilize biochemical and luminescence-based
approaches to determine the V8 cleavage site on PAR1. We will treat mice with pharmacological antagonists
against PAR1 and utilize PAR1-/- mice to determine effects on V8-protease and S. aureus induced itch. In
Specific Aim 3, we will utilize genetic approaches to ablate specific skin-innervating neurons (Nav1.8+, Mrgprd+,
and Trpv1+) to assay their roles in S. aureus induced inflammation. We hypothesize that neurons will drive both
itch/scratch-induced damage, and the release of neural mediators that directly signal to immune cells. We will
use targeted approaches and proteomics to assess neuronal release of proinflammatory mediators. Our work
could elucidate novel molecular crosstalk between S. aureus, host neurons and immune cells in itch. The three
aims of this study leverage the complementary skills of Dr. Chiu and Dr. Horswill, combining neurobiological,
immunological, and microbiological approaches to investigate the mechanisms of itch and neuroimmune
signaling in S. aureus infection. Given the importance of itch in skin diseases, elucidating a microbial role in
inducing this sensation could transform our understanding of host-microbe interactions at the skin barrier.

Public health relevance
PROJECT NARRATIVE Staphylococcus aureus is a leading cause of human skin infections and is associated with itchy skin lesions in patients with Atopic dermatitis and Impetigo. Here, we investigate the role of S. aureus and its secreted proteases in driving itch during infection, and the role of neurons in mediating skin immune responses. Our study could reveal novel mechanisms of itch and inflammation.